Mendelian imputation for family-based GWAS and association-by-proxy in diverse ancestries

Project Summary/Abstract
For this application, “Mendelian imputation for family-based GWAS and association-by-proxy in diverse
ancestries,” we propose to develop methods to enable more powerful estimation of family-based genome-
wide association studies (GWASs) and apply these methods to a wide range of health, disease, and aging
phenotypes in diverse populations. In brief, we propose to:
· Meta-analyze family-based GWAS summary statistics on 30 phenotypes from 14 cohorts of
predominantly European ancestry. In addition, through collaboration with the China Kadoorie Biobank
and 23andMe, we will perform family-based GWAS in a set of diverse ancestries. Using the summary
statistics, we will test within- and cross-ancestry prediction using polygenic indexes (PGIs, also called
polygenic scores) derived from family-based and standard GWAS summary statistics, enabling us to
determine the role of confounding in the drop in predictive accuracy of PGIs across ancestries. We will
investigate methods that combine standard GWAS summary statistics and family-based GWAS
summary statistics to improve polygenic prediction across ancestries.
· Boost the power of family-based GWAS by adding genotyped individuals without any close relatives to
the estimation sample. We will derive analytical formulas that can be used to quantify the efficiency
gains in specific settings. We will develop an efficient linear mixed model algorithm that simultaneously
performs standard- and family-based GWAS, maximizing power for both. Preliminary results from UK
Biobank indicate this method results in an increase in effective sample size for estimation of direct
genetic effects of between 30 and 40%.
· Increase power for association-by-proxy methods by imputing relatives’ genotypes. Theory shows that
power for discovery of associations could be increased when the genotype of the un-genotyped relative
is imputed to give a more accurate estimate of the relative’s genotype. We will apply the methods to
phenotypes available for UK Biobank participants’ parents, including Alzheimer’s disease and longevity.
· Extend the algorithm for imputing parental genotypes to diverse populations and additional relatives.
We will develop an algorithm that uses a diverse haplotype reference panel as the basis of pedigree-
based imputation. In addition to removing bias from imputation in diverse samples, our approach will
generalize the imputation algorithm to include relatives other than full-siblings and parents, thereby
increasing imputation accuracy and power of downstream family-based genetic association analyses.
The software for implementing the methods will be made publicly available on a GitHub repository. The
summary statistics will be made publicly available to the maximum extent consistent with data use agreements.

Public health relevance
Project Narrative This project aims to identify genetic variants that causally influence a range of health, disease, aging, and behavioral phenotypes in diverse populations. Existing evidence from genetic association studies are confounded by environmental factors that may be correlated with genetic variants. Using new data from family- based studies and new statistical tools we are developing, we will be able to identify causal influences, study more diverse populations, and in some cases, increase statistical power.